Developmental Research Program

Project Abstract/ Summary (DRP)
Breast cancers frequently harbor specific patterns of homologous recombination (HR) DNA repair defects (HRD)
and/or specific patterns of genetic instability, namely chromosomal instability (CIN) and APOBEC mutagenesis.
These alterations are present in a substantial proportion of breast cancers and they are enriched in metastatic
disease. Biomarkers to identify these patients reliably and to define the optimal treatments for these patients are
sorely needed. The Developmental Research Program (DRP) will play an important role in fostering translational
research endeavors focusing on breast cancer, in particular research addressing specific patterns of DNA repair
defects and/or genetic instability and their molecular basis. We will use DRP funding supplemented by a strong
commitment of institutional funds to support innovative projects by new and established investigators, which are
critical to the generation of new ideas in the diagnosis and treatment of this large subset of breast cancers. Our
goal is to establish mechanisms for rapid funding of important new directions to accelerate progress towards the
translational research goals of our SPORE. We identified a credible portfolio of promising developmental
research projects, which will be competing for support once the program is established. We will request pilot
project proposals with translational potential from clinical and basic investigators within the larger MSKCC
community, including Rockefeller University, New York-Presbyterian Hospital and Weill Cornell Medical College
of Cornell University. We will then select the most promising new projects for support after rigorous peer review
by the Leadership Committee, the Internal Advisory Board and the Patient Advocates. The opinion of external
reviewers will be solicited as needed. Pilot projects will be funded for 1 year, but investigators may apply for
additional funding through this same competitive process the next year. Every year the Advisory and Leadership
Committee members will meet to review each research project, core, career enhancement project and
developmental pilot project. Committee members will be asked to assess whether any developmental project
has progressed sufficiently and shown enough translational potential, so as to eclipse one of the full SPORE
Research Projects. The committee members will then vote and decide whether any developmental project should
be advanced to full project status. If so, the budgets will be appropriately adjusted and sent for approval with the
TRP of the NCI.

Public health relevance
Project Narrative/Relevance The goal of the Developmental Research Program (DRP) is to expand the investigator base and scope of translational research in breast cancer cancers with specific patterns of DNA repair defects and/ or genetic instability. We will use DRP funding supplemented by a strong commitment of institutional funds to support innovative projects by new and established investigators, which are critical to the generation of new directions in breast cancer research and to meet our translational objectives.